Elucidating the Mechanisms and Relevance of Cocaine-Induced Plasticity of Inhibitory G Protein Signaling in the Prelimbic Cortex

PROJECT SUMMARY
Like other drugs of abuse, psychostimulants enhance dopamine (DA) neurotransmission from the ventral
tegmental area (VTA) to downstream targets including the medial prefrontal cortex (mPFC) and nucleus
accumbens (NAc). Direct stimulation of VTA DA neurons in rodents is reinforcing and sufficient to trigger an
array of molecular, cellular, and behavioral adaptations linked to addiction. Psychostimulants can weaken
inhibitory G protein-dependent signaling in VTA DA neurons and layer 5/6 pyramidal neurons of the prelimbic
(PL) sub-region of the mPFC via suppression of G protein-gated inwardly rectifying K+ (GIRK) channel activity.
In layer 5/6 PL pyramidal neurons, for example, repeated cocaine exposure in mice weakens GIRK channel
regulation by the GABAB receptor (GABABR) in a DA- and phosphorylation-dependent manner. Genetic
suppression of GIRK channel activity in PL pyramidal neurons of drug-naïve mice evokes some of the cellular
and behavioral hallmarks of repeated cocaine exposure. The goals of this project are to elucidate the cellular
and neurochemical mechanisms underlying the cocaine-induced suppression of GABABR-GIRK signaling in PL
pyramidal neurons and to investigate the therapeutic potential associated with rescuing this signaling pathway
in these neurons. Proposed experiments test key elements of the following conceptual framework: Cocaine
provokes the D1 DA receptor-dependent excitation of PL GABA neurons, driving the feedforward inhibition of PL
pyramidal neurons. Repeated GABAergic input to PL pyramidal neurons promotes the suppression of the
GABABR-GIRK signaling pathway. Weakening of this inhibitory signaling pathway contributes to the
hyperexcitability of PL pyramidal neurons, which promotes aberrant behaviors associated with repeated cocaine
exposure. Mechanism-informed interventions that restore or strengthen the GABABR-GIRK signaling pathway in
PL pyramidal neurons, therefore, will normalize behaviors linked to repeated cocaine exposure. There are two
Specific Aims: 1) Elucidate mechanisms underlying the cocaine-induced hyperexcitability of PL pyramidal
neurons. Using slice electrophysiological approaches, I will test the hypothesis that D1R activation of PL GABA
neurons drives the feedforward inhibition of PL pyramidal neurons necessary for the cocaine-induced
suppression of GABABR-GIRK signaling. 2) Test whether mechanism-informed interventions can rescue
cocaine-induced behavioral deficits. Using complementary pharmacological and neuron-specific viral genetic
interventions, I will test the hypothesis that mechanism-informed interventions that rescue and/or strengthen
GABABR-GIRK signaling in PL pyramidal neurons can alleviate behavioral deficits provoked by repeated cocaine
exposure in mice. Successful completion of this project will advance our understanding of the mechanisms and
relevance of cocaine-induced suppression of GABABR-GIRK signaling in PL pyramidal neurons, and provide
valuable training in ex vivo electrophysiology, intracranial genetic and pharmacological manipulations, and
behavioral analysis in mice, building a strong foundation for my future career as an independent investigator.

Public health relevance
PROJECT NARRATIVE Despite the prevalence and adverse consequences of psychostimulant use disorders, there are no FDA- approved interventions for their treatment. Recent work has shown that repeated cocaine exposure in mice weakens an inhibitory signaling pathway in the prefrontal cortex and that this adaptation is sufficient to provoke an array of cellular and behavioral hallmarks of addiction. The proposed research seeks to define the cellular and neurochemical mechanisms underlying this neuroadaptation and to evaluate the therapeutic potential of strengthening this inhibitory signaling pathway to reverse the consequences of repeated cocaine exposure.